MAPPING CEREBRAL AREAS RECEIVING AFFERENT SENSORY IMPUT

The purpose of this study is to determine whether magnetic resonance imaging can determine which areas of the brain sense distention of the esophagus, stomach and rectum.